Non-invasive, continuous blood pressure monitoring for prenatal maternal health

Project Summary/Abstract -- Non-invasive, continuous BP monitoring for prenatal maternal health
Hypertensive disorders affect up to 15% of pregnancies and can lead to serious complications for both
mother and child. Preeclampsia is the most severe hypertensive disorder during pregnancy. In addition to
being the second leading cause of maternal mortality worldwide, it is responsible for up to 2.6 million
premature births and about 0.5 million infant deaths each year. Timely intervention can mitigate the impact of
gestational hypertension but requires close monitoring of blood pressure (BP) which is difficult to achieve over
the weeks of late pregnancy where the patient is at greatest risk. There is a critical need for a BP
monitoring device for prenatal care that is comfortable, accurate, and easy to use.
PyrAmes has developed a comfortable wearable device to collect arterial pulse waveform data to monitor BP
in real time using a combination of capacitive pulse sensing and machine learning techniques. The technology
was pioneered by our co-founder/advisor, Stanford Prof. Zhenan Bao, and is exclusively licensed to PyrAmes.
The system uses lightweight neural networks to analyze pulse waveform data to provide continuous
determination of systolic, diastolic, and mean BP, heart rate, and their variabilities. The sensor is easy to use
and non-invasively records waveform data similar to an arterial line, while avoiding the difficulties and
risks of placing and maintaining an arterial line. It can provide results comparable to gold standard arterial line
monitoring without perturbing the patients for more timely and accurate measurements than possible with cuffs.
PyrAmes’ Boppli™ device for infants is based on this technology and received FDA Breakthrough Device
Designation. It is in pilot production and is currently FDA review based on data from a multi-site pivotal study to
collect pulse waveform data from preterm neonates in the NICU with an arterial line in place, with a primary
objective of measuring BP within the FDA guidelines for accuracy.
The objective of the R61 phase is to extend PyrAmes’ platform to monitor pregnant women. This goal will be
consenting expectant mothers receiving blood pressure measurements during office visits or when hospitalized
before delivery. We will use the data collected in the proposed study to refine the artificial neural networks
used to extract BP values from the PyrAmes pulse waveform data with a focus on obtaining more accurate
results for pregnant women. Our success metric for this study on expectant mothers will be to exceed the
quality and accuracy of our preliminary models for these women. We also plan to determine if the pulse
waveform shape can serve as a timely biomarker of hypertensive disorders that can occur during pregnancy.
The R33 phase will include a follow-up IRB-approved validation study using the device and models from the
R61 phase to position our device for FDA clearance and to scale up to pilot production of this device.

Public health relevance
Project Narrative -- Non-invasive, continuous blood pressure monitoring for prenatal maternal health The goal of this proposal is development of a non-invasive device that is comfortable, low-cost and easy to use in order to monitor the blood pressure and changes in the pulse waveform shape of pregnant women. Close surveillance of women at risk of developing complications from hypertensive disorders of pregnancy potentially enables timely diagnosis and treatment before they develop significant maternal and neonatal morbidities related to hypertensive disorders of pregnancy, such as pre-eclampsia. This project is based on technology invented in Prof. Zhenan Bao’s lab at Stanford University and a fully-functional prototype device, and includes prospective data collection, usability and validation studies with women at different stages of pregnancy.